Mechanisms Promoting Cellular Tolerance to Fungistats

Summary
Fungal infections cause significant morbidity and mortality, particularly in immunocompromised individuals.
Most infections are initially treated with Fluconazole or a related azole-class antifungal, which all target sterol
biosynthesis enzymes in the endoplasmic reticulum and arrests growth of the pathogen without directly
killing it. A serious limitation of these fungistats is the emergence of resistance, in addition to potential for
relapse upon withdrawal. Remarkably, azoles can be converted to fungicides by other drugs that specifically
inhibit the protein phosphatase calcineurin. The calcineurin inhibitors do not strongly affect resistance
mechanisms or change the potency of fungistats. Instead they alter tolerance mechanisms that help the
pathogens survive long-term antifungal assaults. Previous studies have focused on how fungistats trigger the
activation of calcineurin. This project aims to reveal the downstream effectors of calcineurin that specifically
regulate tolerance to the fungistats. Two unbiased screening approaches will be utilized to help define new
components of the calcineurin-dependent tolerance mechanism. First, we will utilize a mass spectrometry
approach to identify phospho-proteins in a model yeast that change phosphorylation state in response to
calcineurin inhibitors during exposure to model fungistats (ER stressors). Second, we will develop a novel
genetic approach and conduct the first genome-wide genetic screens in the human opportunistic pathogen
Candida glabrata to identify genes that specifically regulate tolerance to Fluconazole. Genes that regulate
resistance to Fluconazole also will be identified and categorized. This approach, termed Hermes insertion
profiling (HIP), involves in vivo random mutagenesis of the C. glabrata genome using a transposon and
Illumina sequencing of the insertion sites. The combination of these unbiased approaches in different yeast
species exposed to different fungistat classes provides complementary views of the underlaying tolerance
mechanism. Together, a common set of genes/proteins is unveiled whose activities respond to calcineurin in
fungistat-stressed cells and regulate tolerance. We propose a series of genetic, biochemical, and cell biological
experiments in both yeast species to test several hypotheses about their interactions with one another and their
order of action within the calcineurin-dependent tolerance mechanism. These experiments are expected to
reveal at least 5 new components in the cascade that act sequentially: the kinases that synthesize inositol
pyrophosphates, the protein kinase CK2, the ER enzyme ceramide synthase and its product, and a putative
ceramide-activated protein phosphatase. The project therefore provides immediate insights into new therapies
that can kill fungal pathogens while establishing a paradigm for tolerance mechanisms that may operate
broadly in nature.

Public health relevance
Mechanisms Promoting Cellular Tolerance to Fungistats Narrative Fungal infections kill more than one million people each year and sicken millions more. Our first-line antifungals do not kill pathogenic fungi because their cells enact a survival response. By defeating this survival response, we can greatly improve the potency of existing therapeutics. This project will define critical new components of the survival response and will reveal an entirely new strategy that could be used to control pathogenic fungi and eukaryotes, and perhaps even tumors.